Pdcd4-Rictor Interaction in Suppression of Lung Tumorigenesis

Project Summary/Abstract
Lung cancer is the leading cause of cancer-related deaths in the United States. The high mortality rate is not
only due to the lack of effective early detection but also due to poor tumor response to currently available
therapies. These underscore the urgent need to better understand the biological events and mechanism of lung
cancer suppression, as is the need for important new therapeutic approaches that specifically target these
processes to improve survival rates. Lung cancer is mainly divided into two types: small cell lung cancer (SCLC)
and non-small cell lung cancer (NSCLC), the latter of which accounts for 80-85% of all cases. A new subset of
lung cancer in both SCLC and NSCLC was recently identified in which Rapamycin-insensitive companion of
mTOR (Rictor) gene is amplified. Rictor is an essential component of the mammalian target of rapamycin
complex 2 (mTORC2) and is required for mTORC2 complex activity and integrity. Activation of mTORC2 results
in promotion of cancer cell proliferation and survival. This application builds on exciting preliminary data that
Programmed cell death 4 (Pdcd4) bound with Rictor through a Rictor binding domain (RBD) to inhibit mTORC2
activity, 6-phosphofructo-2-kinase/fructose-2,6-biphosphatase 3 (PFKFB3) level, cell proliferation, and colony
formation. In addition, a peptide containing the RBD specifically inhibits mTORC2 but not mTORC1. Our data
further demonstrated that the RBD peptide suppressed NSCLC proliferation in cultured cells and nude mice. The
central hypothesis is that Pdcd4-Rictor binding specifically inhibits mTORC2 to preferentially suppress
proliferation in Rictor-elevated NSCLC via induction of proteasomal degradation of PFKFB3. To test this
hypothesis, three specific aims are proposed: i) Delineate the mechanism of how Pdcd4-Rictor binding interferes
with mTORC2 activity to suppress tumor growth in NSCLC; ii) Dissect how Pdcd4-Rictor-mTORC2 axis impacts
PFKFB3 stability and metabolic pathways; iii) Demonstrate that mTORC2-specific inhibition by RBD peptide
preferentially suppresses the growth of Rictor-elevated NSCLC to improve survival rate. The accomplishment of
the proposed study will not only uncover novel regulatory mechanisms of mTORC2 activity and PFKFB3
expression by Pdcd4 but also reveal the importance of mTORC2-specific inhibition by RBD peptide on NSCLC
tumorigenesis. The expected findings will guide us to develop new strategies that are particularly relevant to
precision medicine approaches for NSCLC patients with elevated Rictor.

Public health relevance
Project Narrative Lung cancer is the most commonly diagnosed cancer and the first leading cause of death in both men and women in the United Sates. In this proposal, we intend to understand of how Pdcd4, a tumor suppressor, binds with Rictor, an important protein, in suppression of the lung cancer cells. This work will provide new strategies for lung cancer with Rictor elevation therapeutics and potentially develop new agents for treatment of this type of lung cancer.